IGF::OT::IGF FY15- IWIN; NAVIGATING YOUR PATH TO WELL BEING; SBIR PHASE II. BASE AWARD. PERIOD OF PERFORMANCE 9/1/2015-8/31/2017

The overarching objective of this proposal is to conduct a randomized trial to evaluate the effectiveness of the Individual Well-Being Navigator (iWin) mobile application, a substance abuse prevention and well-being enhancement program designed specifically for military personnel. This broad objective is driven by five specific activities and deliverables.